Endogenous Circular RNAs limit abemaciclib anti tumor immune responses

ABSTRACT
Soft-tissue sarcomas (STS) pose a substantial global health challenge with a low survival rate for advanced
cases. Despite current treatments, there is a pressing need for effective therapeutic strategies. This proposal
focuses on investigating the potential of Abemaciclib, a CDK4/6 inhibitor, alone or in combination with circRNA-
silencing, to enhance anti-tumor immune responses in STS. The study aims to elucidate the interplay between
Abemaciclib, circular RNAs (circRNAs), and immune responses in STS using newly developed
immunocompetent mouse models. The research is structured around three specific aims: Aim 1 explores how
circCsnk1g3 limits Abemaciclib-triggered interferon and inflammatory responses. Abemaciclib and circCsnk1g3
exhibit opposing effects on these responses in sarcoma cells, and the study aims to uncover the shared signaling
pathway impacted by both. Experimental approaches include treating with Abemaciclib, manipulating
circCsnk1g3 expression, and assessing the RIG-I/MDA5/MAVS pathway through co-immunoprecipitation
assays and downstream effector evaluation. Aim 2 investigates whether circCsnk1g3 silencing enhances
Abemaciclib's anti-tumor effects and shapes the tumor microenvironment (TME). The study hypothesizes that
circCsnk1g3 targeting could serve as a therapeutic adjuvant to boost Abemaciclib-induced anti-tumor immune
responses. Advanced techniques such as single-cell RNA-sequencing and flow cytometry will be employed to
comprehensively assess tumor immune composition, including sub-types of tumor-associated macrophages
(TAMs) and T cells. Aim 3 assesses the functional role of circCdyl in regulating TAM inflammatory responses.
TAMs express higher levels of circCdyl and RIG-I than sarcoma cells, and the study aims to determine the impact
of circCdyl on TAM activation and anti-tumor effects. Intervention with circCdyl expression in bone marrow-
derived macrophages (BMDM) will be conducted, and in vivo experiments will assess the influence of circCdyl-
manipulated BMDM on tumor growth. Overall, this research aims to deepen our understanding of the
mechanisms underlying the potential synergy between Abemaciclib and circRNA-silencing in STS, with a focus
on immune responses and the tumor microenvironment content.

Public health relevance
NARRATIVE This proposal will illuminate the molecular mechanisms used by circCsnk1g3 to limit abemaciclib- induced inflammatory responses in the sarcoma cells (Aim 1), and the microenvironment changes induced by combining abemaciclib with circCsnk1g3-silencing (Aim 2). Additionally, we will define whether and how circCdyl impacts on tumor-associated macrophages activation and functions upon abemaciclib treatment (Aim 3).